REGULATORS OF EPIDERMAL GENE EXPRESSION

REGULATORS OF EPIDERMAL GENE EXPRESSION
PROJECT SUMMARY
Epidermal homeostasis is critical for skin barrier function and is disrupted in diseases such as
psoriasis, atopic dermatitis, and skin cancer. During the current funding cycle, AR045192 identified
new essential roles for specific heterogeneous nuclear ribonucleoproteins (HNRNPs) and ubiquitin-
like proteins (UBLs) in epidermal homeostasis. These regulators can exert post-transcriptional and
post-translational impacts, respectively, however their actions in the skin are poorly understood.
This competing renewal will define how these newly uncovered HNRNPs and UBLs mediate
opposing effects on epidermal growth and differentiation.
For HNRNP RNA-binding proteins (RBPs), AR045192 knocked out all 33 HNRNPs to uncover
new roles for HNRNPC and HNRNPU (pro-progenitor) as well as HNRPNH (pro-differentiation) in
epidermal gene expression. HNRNPs exert diverse impacts across RNA lifecycles, however, their
actions in epidermis are understudied. AR045192 therefore used non-isotopic ligation-based UV
crosslinking immunoprecipitation-mass spectrometry to uncover dynamic assemblies of proteins on
mRNAs adjacent to HNRNPC that cooperate with HNRNPC in progenitor mRNA surveillance. Aim I
will further define the identity, assembly dependencies, and functions of proteins co-assembled on
progenitor and differentiation mRNAs with HNRNPU, and HNRNPH to address the emergent model
that specific HNRNPs assemble with distinct combinations of other RBPs on discrete sets of target
RNAs to control epidermal homeostasis
Conjugation to UBLs, including ubiquitin, NEDD8, and SUMO2, can alter a protein’s localization,
interactions, stability, and function, however, roles for UBLs in epidermal homeostasis are not fully
characterized. AR045192 knocked out 124 genes encoding all human UBLs, and the enzymes that
conjugate them to their target proteins to uncover opposing UBL actions in epidermis. The NEDD8
UBL, along with its corresponding NAE1 and UBA3 enzyme subunits, was essential to maintain
undifferentiated progenitor gene expression in human and mouse epidermal cells and tissues. In
contrast, the SUMO2 UBL, along with its SAE1 and UBA2 enzyme subunits, was required for
differentiation. HNRNPU was identified as NEDD8-tagged in undifferentiated keratinocytes and
SUMO2-tagged in differentiating cells; disrupting this reciprocal tagging altered HNRNPU-bound
target RNAs. Aim II will apply new methods to characterize the opposing actions of NEDD8 and
SUMO2 UBLs in epidermal gene regulation.
This effort will expand insight into how specific HNRNP and UBL regulators exert their newly
identified essential impacts on epidermal gene expression.

Public health relevance
REGULATORS OF EPIDERMAL GENE EXPRESSION Project Narrative Self-renewing tissues, like the cutaneous epidermis, require a balance between proliferation and differentiation to maintain human health. This balance is disrupted in common human skin diseases. This project characterizes new regulators that control this process with a goal to enable future applications in biomedicine. 1